WORKSHOPS AND EVALUATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Career Development Core was originally envisioned to strengthen the grant writing skills of the INBRE partners. As detailed in past APRs a grant writing workshop has been offered several times to the INBRE partners at the PUIs, TCUs, and RIUs. Overall, attendance was initially complete and by course end a rapid decline had occurred for all partners. Other than the faculty of the RIUs, very few individuals completed the course. Correlating to this lack of attendance and completion, is a notable lack of extramural grant submission by the PUI and TCU partners over the course of the ND INBRE award. In the later years, the Career Development core has concentrated on program evaluation and the metrics that define student success and technology-based workshops to strengthen the career success of the INBRE students.